CIRCADIAN RHYTHM OF INTRAOCULAR PRESSURE IN HUMAN SUBJECTS

The object of this study is 1) whether statistically and biologically significant differences in IOP occur in subjective dark versus subjective light phases in light-entrained human subjects; and if so; 2) location of the peak and nadir values in relation to the dark and light phases, 3) the goodness of fit of the data to circadian cosinor function tests, 4) whether established CRIOP amplitude prameters for diagnosis of pressure pathology are statistically consistent with the observed results of the proposed study.